Mechanistic studies of alcohol-sleep interactions

Abstract
Sleep dysregulation is a hallmark of alcohol use disorders (AUDs) and disrupted sleep can contribute to
relapse even after months of abstinence. Despite the well-recognized sleep-AUD interactions, few studies
have investigated how sleep changes over the development of excessive drinking, and the mechanisms by
which sleep disruptions exacerbate drinking and/or relapse liability are largely unknown. Based on several key
findings from published studies and preliminary work, one hypothesis is that disrupted REM sleep induces
maladaptive changes in the medial (M) and lateral habenula (LHb), which in turn contribute to escalated
alcohol intake and promote relapse. The key findings are: 1. Specific REM sleep deficits at 2-3 weeks after
alcohol withdrawal are a robust predicting factor for relapse in alcohol dependent patients; 2. Chronic, selective
REM sleep fragmentation enhances medial Hb neuron tonic firing and negative affect; 3. Relapse to alcohol
seeking is associated with increased activation of MHb and LHb neurons. 4. Sleep fragmentation precipitates
drug craving during abstinence from cocaine, while selective consolidation of REM sleep reduces craving.
Thus, it is predicted that chronic alcohol drinking and abstinence leads to disrupted REM sleep, which induces
Hb hyperactivity, promoting a negative affective state that drives motivation for alcohol and relapse. Likewise, it
is predicted that chronic REM sleep disruptions can initiate this cycle, leading to increased risk for developing
AUDs. Therefore, aim 1 in this proposal will evaluate the effects of chronic and escalating alcohol drinking and
abstinence on sleep architecture and Hb neural activity. The proposed experiments will use the intermittent
access two-bottle choice ethanol drinking paradigm combined with chronic EEG/EMG recordings and ex vivo
slice electrophysiology. It is expected that the baseline REM sleep features or the REM sleep deficits following
alcohol drinking/abstinence may predict the amount of alcohol drinking as well as Hb neural activity. Aim 2 will
determine if chronic REM sleep fragmentation promotes the escalation of alcohol intake in the intermittent
access model and/or promotes relapse in an operant self-administration model. We will further determine if the
REM sleep effects on alcohol intake/relapse are, in part, mediated by REM sleep fragmentation-induced
hyperactivity of Hb neurons. Aim 3 will test the treatment potential of interventions that improve REM sleep.
Utilizing recently developed REM sleep-selective manipulations, it will be determined if selective REM sleep
consolidation can reduce alcohol drinking and relapse, and if this is associated with reduced Hb activity.
Overall, the proposed studies will provide a critical assessment of the potential for developing REM sleep-
focused therapeutics for preventing relapse, and provide novel mechanistic insight into the interactions
between alcohol intake and sleep homeostasis in the context of habenula dysregulation. Thus, this proposal is
consistent with the mission of NIAAA RFA-AA-19-006 to perform Mechanistic Studies on Chronic Alcohol Use
and Sleep Homeostasis.

Public health relevance
Project Narrative The proposed studies will investigate the interplay between chronic alcohol use and sleep by determining both how chronic alcohol alters sleep homeostasis and how disrupted sleep promotes alcohol intake. The project will focus on how disruptions to REM sleep and subsequent alterations in medial and lateral habenula neurons mediate increased alcohol drinking and susceptibility to relapse. We will further test if increasing consolidated REM sleep reduces alcohol drinking and relapse, which will inform development of REM sleep-based therapies.